DOES A SHIFT FROM 4R TO 3R TAU PROJECT AGAINST AMYLOID BETA-INDUCED COGNITIVE DEF

DESCRIPTION (provided by applicant): Alzheimer's Disease (AD), the most common form of dementia, is characterized by two pathological hallmarks: tau neurofibrillary tangles (NFT) and amyloid-β (Aβ) plaques. As an alternative approach to current Aβ-targeted therapies, we propose to focus on tau. Several groups have shown that mice lacking endogenous tau, when crossed to Aβ depositing hAPP mice, show a significant increase in learning/memory performance and are protected from chemically induced seizures. Our preliminary data show that, as predicted from the tau knockout, lowering total tau protects against seizures. Surprisingly, we also have found that converting the 4R tau isoform to 3R tau without changing total tau also protects against seizures. We now propose to determine whether converting 4R tau to 3R will protect against amyloid beta induced cognitive deficits in PSAPP mice. In addition, using measures of neuronal excitability in response to GABA antagonists, we will correlated the amount of tau knockdown and shift from 4R to 3R with the change in neuronal excitability. Using immunohistochemical and biochemistry, we test whether changing tau isoforms changes tau localization or the components of the synapse. The antisense oligonucleotide approach used in this grant to modify tau has been used successfully in a Phase I clinical trial for patients with ALS. Thus, demonstrating a therapeutic benefit using oligos that change 4R to 3R in mice may be readily translatable to human.

Public health relevance
There are no medications that substantially slow the course of Alzheimer's disease. The results of this application have the potential to validate a novel approach to treating Alzheimer's disease by demonstrating that changing the ratios of different forms of the protein tau improves cognitive performance in mice. Since the antisense oligonucleotide strategy used here is currently being used in humans in other neurodegenerative diseases, the results from this grant may be readily translated to humans and may result in a new therapy for Alzheimer's disease.